Gene-environment interaction pathways in rheumatoid arthritis

ABSTRACT
Shared epitope (SE)-coding HLA-DRB1 alleles confer the single strongest genetic risk for severe RA. In
addition to genetic predisposition, exposure to environmental pollutants, such as dioxin-like compounds, and
tobacco smoke strongly affect RA risk and severity. Furthermore, interactions between SE and tobacco smoke
exposure has been shown to increase the risk for RA in a multiplicative, dose-dependent fashion. The
mechanistic basis of this epidemiologically observed gene-environment interaction is unknown.
We have recently uncovered an NF-kB-mediated crosstalk between the SE and aryl hydrocarbon receptor
(AhR) pathways that lead to synergistic effects on osteoclast differentiation and Th17 polarization in vitro.
Administration of AhR pathway agonists to transgenic mice carrying human SE-coding alleles resulted in a
robust increase in arthritis severity, bone destruction and overabundance of osteoclasts and IL17-expressing
cells in the inflamed joints and draining lymph nodes of arthritic mice. Thus, we have uncovered a previously
unrecognized mechanism of gene-environment interaction.
The studies proposed here will focused on detailed characterization of the newly uncovered synergism by
defining the transcriptomic effects of the SE ligand, AhR agonists, and their combination. The physiologic
relevance of the findings will be corroborated in in vivo mouse systems, as well as by human translational
studies. The proposed research will have the following specific aims:
 To identify and map the synergistic pathways using an RNA-seq approach
 To determine the effect of the interaction on chromatin accessibility and validate transcription factor
activation
 To validate interacting pathways in mice exposed to AhR agonists
 To determine pathway interactions in human cell lines and primary cells
When successfully completed, the proposed project will have identified new pathogenic mechanisms and
disease risk and severity markers in RA. Such findings will open the door to identification of new
therapeutic targets that could be pursued in future research projects.

Public health relevance
PROJECT NARRATIVE (Public Health Narrative) Disease risk in rheumatoid arthritis is affected by both genetic and environmental factors. In recent studies we have uncovered a mechanism that explains how genetic risk factor for RA and an environmental pollutant work together to amplify disease development in mice with an experimental model of RA. In this project we will identify cellular pathways that mediate the increased risk and disease severity.